Symptom clusters in children with exacerbation-prone asthma

PROJECT SUMMARY/ABSTRACT
Asthma symptom control is suboptimal in the majority of children in the United States, despite widespread
availability of asthma controller medications and standardized treatment guidelines. While deaths from asthma
have declined, more than 50% of children with asthma experience an exacerbation each year and the public
health burden is substantial. While the factors associated with asthma symptom control are complex, it is also
recognized that children with exacerbation-prone asthma are a heterogeneous group, with differing symptom
profiles that may contribute to differing clinical outcomes. However, existing research on asthma symptoms in
this age group is quite limited and has focused primarily on respiratory symptoms in isolation, ignoring other
physical symptoms and symptoms of mental and social health that are important to overall functional status
and quality of life. To date, there has been no attempt to comprehensively identify and phenotype symptom
clusters (defined as two or more concurrent symptoms independent of other clusters) in children with
exacerbation-prone asthma. Given this major shortcoming, this 48-week cohort study (N=173) will test the
overarching hypothesis that symptom clusters and their associated inflammatory and metabolic pathways
predict corticosteroid treatment responsiveness (primary objective outcome) and quality of life (patient-reported
secondary outcome) in children 8-17 years with exacerbation-prone asthma. Specific aims are to: 1) identify
and phenotype symptom clusters and assess their temporal trajectories, 2) determine associations between
symptom clusters and clinical outcomes, and 3) identify inflammatory and metabolic pathways underlying
symptom clusters in children with exacerbation-prone asthma. We anticipate that a cluster of children with the
poorest physical, mental and social health symptoms will emerge; we further anticipate that the symptom
presentations in this cluster of children will be stable over time and will result in the poorest corticosteroid
treatment responsiveness, the poorest quality of life, and the greatest magnitude of inflammation. This project
involves a multidisciplinary team with a history of collaboration and is aligned with the NINR Strategic Plan to
“Advance Symptom Science Research” in chronic conditions through biobehavioral research. Expected
deliverables from this project include: 1) refined knowledge regarding the identification and clinical utility of
symptom clusters in children with exacerbation-prone asthma, and 2) identification of mechanisms underlying
symptom clusters that can be targeted in future interventional studies. Because children with exacerbation-
prone asthma rarely report a single symptom, these discoveries have the potential to significantly advance
individualized treatment and improve clinical outcomes, ultimately reducing the high morbidity and improving
quality of life in affected children.

Public health relevance
PROJECT NARRATIVE Children with exacerbation-prone asthma are a heterogeneous group with differing symptom presentations that likely contribute to differing longitudinal clinical outcomes. Given extremely limited symptom science in this population, the primary objective of this cohort study is to refine knowledge of symptom clusters, their temporal trajectories, and their associations with corticosteroid treatment responsiveness and quality of life in children with exacerbation-prone asthma. Secondary goals are to identify inflammatory and metabolomic biomarkers that can be targeted in future personalized intervention studies to reduce morbidity and costs.